Host response and liver disease in a hepatitis C-like virus rat model

Project Summary (Abstract)
Approximately 170 million people are chronically infected with hepatitis C virus (HCV). The virus causes
about a million deaths and 2-3 million new infections each year. HCV establishes chronic hepatotropic infection
in the majority of infected individuals. However, not all chronically infected persons develop liver diseases. The
viral and host factors, and their interactions, that determines the development of HCV persistence and liver
diseases remains obscure largely due to the lack of an appropriate small animal model. Notably, HCV induced
liver diseases develops after years or decades of persistent viral infection in humans, the natural host of HCV,
and therefore an informative liver disease model should develop long term viral persistence leading to chronic
liver inflammation and diseases. Only chimpanzees can serve as immunocompetent hosts to study HCV infection
but are unavailable. Considering the strict species tropism of HCV, the best alternative is to develop a surrogate
model where the virus and its infection in the host mirror HCV infection in humans and chimpanzees. GBV-B
served as an informative surrogate model but it mostly causes acute resolving infection (of a few months). Rodent
hepaciviruses (RHV) are animal homologs of HCV. We isolated a RHV from wild rats (Rattus norvegicus),
designated RHV-rn1 (preliminary data). We determined that RHV-rn1 possesses HCV’s defining hallmarks:
hepatotropism, propensity to life-long persistence and slow progressing liver disease. Immune responses elicited
by RHV-rn1 and HCV are similar including the induction of interferon stimulated genes in the liver during acute
and chronic viral infection Taken together, we showed that RHV-rn1 infection of immunocompetent rats is an
innovative model to study HCV-related persistence and pathogenesis. We propose to characterize the host
factors that dictate viral infection outcomes and diseases. Since, their better characterization is critical for
developing new means of preventing viral persistence and diseases. Aim-1 is to study natural history of virus
pathogenesis and dynamics of innate immune responses culminating in different infection outcomes and liver
pathologies. Aim-2 is high-resolution mapping of innate immune responses in the liver of infected rats. We will
study serial gene expression changes using cell-type specific and single-cell RNA-seq analysis of virus infected
and uninfected hepatocytes, sinusoidal endothelial cells, Kupffer cells and natural killer cells. Aim-3 is to target
the viral genomes and specific innate immune responses for achieving virus clearance or averting liver diseases.
We will use miRNA expressing Adeno-associated virus (AAV) vectors to inhibit virus replication or repress/de-
repress host gene expression. Consequently, we will know the precise role of the targeted host responses in
hepacivirus persistence and pathogenesis. We believe that the proposed studies will provide unprecedented
insights into the in vivo relevance of host responses during HCV pathogenesis. Additionally, further
characterization of our novel fully immunocompetent and tractable model will allow development of innovative
means to prevent viral persistence and liver diseases.
!

Public health relevance
Public health relevance An estimated 2-3% of the world’s population is chronically infected with hepatitis C virus. Each year, 3–4 million people are newly infected with HCV and 476,000 patients die from HCV-associated end-stage liver disease and its complications. We will develop a tractable surrogate animal model to study HCV-related viruses for studies of virus infection and pathogenesis. Our studies will provide new insight into the immunopathogenesis of these viruses paving the way for the development of strategies to prevent HCV-driven diseases. !